Maryland Population Research Center

PROJECT SUMMARY
This application requests a fourth consecutive five-year cycle of NICHD Population Research
Infrastructure Program support to the Maryland Population Research Center (MPRC) at the
University of Maryland (UMD). The MPRC is an interdisciplinary center at the University of
Maryland-College Park that supports the research of 96 population researchers across 8
different schools or colleges and 20 departments. Over the next fiveyear period, MPRC will
support the Primary Research Areas of Gender, Family, and Social Change, Health in Social
Context, Social and Economic Inequality, and Migration and Immigrant Processes, and will
support innovations in data and methods for population research across these substantive
areas. This support will be provided by three cores that are central to increasing the pace and
impact of population science research: Administrative, Scientific and Technical, and
Development. Their missions are to meet the infrastructure needs of population scientists, to
foster an interdisciplinary intellectual environment, and to promote the development of junior
and underrepresented minority scholars in population research. The Administrative core will
support the preparation of grant applications, post-award project management, and will assist
other cores. It will deploy web-based tools to enhance Center activities and will provide scholars
effective means of managing research collaborations and disseminating research. The Scientific
and Technical Core will manage the computing resources, provide confidential data access
including the National Survey of Adolescent to Adult Health, and will provide statistical
computing short courses and consulting, all vitally supporting empirically-focused population
research. The Core will also expand associates’ research using restricted data access across
the federal statistics agencies by participation in the leadership of, and sponsoring symposia on
the use of data within, the new Federal Statistics Census Research Data Center (RDC) recently
established at UMD. The Development Core will promote the intellectual community of
population research at UMD through seed grant programs and by organizing a weekly seminar
series, specialist workshops and working groups, and by cosponsoring conferences and
symposia. The Core also supports resident population scientist and visiting population scientist
programs that provide a primary institutional and physical home for population researchers
permanently and temporarily based at UMD. Taking advantage of our location in the
Washington, DC area, MPRC will promote the research of our associates through linking to the
research and data activities of federal agencies in the Washington, D.C., including through
support to biennial workshops and conferences on time use research using the American Time
Use Survey and its international counterpart surveys. Infrastructural support for data collection
encompasses the large-scale survey research of the India Human Development Survey through
to smaller-scale data collections on the reproductive health among women in Delaware and on
kin support to low-income single mothers in Nairobi.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) The MPRC promotes research that is central to the NICHD Popula�on Dynamics Branch mission, in areas of demographic research, popula�on and health, and reproduc�ve health and HIV/AIDS research.